Integrated proteomic and metabolomic biomarker profiling for understanding metabolic syndrome in pregnant women living with HIV on Tenofovir Disoproxil Fumarate/Lamivudine/Dolutegravir (TLD)

PROJECT ABSTRACT/SUMMARY
Effective HIV treatment during pregnancy is critically important, both for the health of women living with HIV
(PWHIV) and for prevention of perinatal HIV transmission. In the United States, Nigeria, and globally,
Dolutegravir (DTG)- based antiretroviral therapy (ART) is being expanded as part of the preferred 1st-line ART
regimen, but emerging data show that DTG-based regimens are associated with excessive weight gain,
treatment-emergent obesity, and metabolic dysfunction in PWHIV. Excessive weight gain and metabolic
syndrome are critical during pregnancy because they increase the risk for pregnancy-related complications, such
as preterm birth, pre-eclampsia, gestational diabetes, fetal obesity, macrosomia, low birth weight, Cesarean
delivery, and neonatal intensive care unit admissions. Yet, the mechanisms by which DTG-based ART-cause
weight gain and metabolic syndrome in PWHIV are poorly understood, limiting our ability to fully deploy DTG-
based ART in this special population. To address this goal, we will leverage NIH infrastructure to conduct a
prospective cohort study at 4 sites in two countries (US and Nigeria). Within this cohort, we will first identify cases
of metabolic syndrome by examining the association between DTG-based ART regimens and metabolic
syndrome risk using the National Cholesterol Education Program Adult Treatment Panel III (NCEP ATP III)
criteria for pregnant and postpartum women living with HIV, and cohort-specific percentiles for waist
circumference, systolic blood pressure, and serum glucose for their offspring. Subsequently, among PWHIV
diagnosed with metabolic syndrome (compared to controls), we will apply advanced integrated proteomic and
metabolomic targeted profiling techniques to measure maternal proteins and metabolites (during pregnancy and
postpartum) and umbilical cord blood proteins and metabolites to understand whether signature clusters of
proteins and metabolites differ between PWHIV diagnosed with metabolic syndrome (compared to selected
controls), and if any signature clusters are associated with adverse maternal and child metabolic health.
Biomarkers identified through integrated profiling would enhance the synergistic power of these ‘omics’
approaches to enable early detection of metabolic syndrome (even before clinical symptoms manifest), provide
insights into treatment efficacy and potential adverse effects, and contribute to the development of personalized
medicine strategies for PWHIV to guide the selection of interventions and therapies tailored to specific metabolite
profiles in clinical practice.

Public health relevance
PROJECT NARRATIVE: Effective antiretroviral therapy (ART) is critical during pregnancy for women living with HIV (PWHIV) for optimal maternal and fetal health, but there are knowledge gaps in pharmacology of new HIV drugs, adverse effect profile, and safety in pregnancy that prevent efficient and effective deployment of our most promising new ART in pregnant women. The objective of this proposal is to advance our knowledge of adverse effect profile associated with -- Dolutegravir (DTG), Tenofovir Disoproxil Fumarate (TDF), and Lamivudine drug combination --in PWHIV and their offspring, using advanced “omics” technologies (integrated proteomics and metabolomics). Research goals include clinical and biomarker characterization of metabolic syndrome, and providing insights into the mechanistic intricacies of metabolic syndrome in large community-based cohorts of black and white PWHIV in the US and Nigeria, with the overall goal of optimizing HIV therapeutics for PWHIV.